DECIPHERING ENZYME SPECIFICITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. A Program Project from NIGMS that is focused on developing computational approaches for predicting the substrate specificities of unknown members of the mechanistically diverse enolase and amidohydrolase superfamilies.